CD38 modulation of NAD metabolism driving scleroderma pathogenesis

PROJECT SUMMARY/ABSTRACT
In systemic sclerosis (SSc), fibrosis causes permanent functional damage in multiple organs. While
non-resolving fibrosis in SSc has lethal consequences, its mechanisms are poorly understood and there is no
effective treatment. Based on our exciting findings, we now propose the very novel hypothesis that fibrosis results
from dysregulation of nicotinamide adenine dinucleotide (NAD) and nicotinamide (NAM) metabolism mediated
by the enzymes CD38 (which breaks down NAD to NAM), and nicotinamide N-methyltransferase (NNMT), which
couples cellular metabolic states to methylome changes and cellular reprogramming. Moreover, we propose that
this multicellular CD38-NNMT metabolic axis represents a novel target for SSc therapy. Our preliminary results
show that 1) expression of CD38 and NNMT are elevated in SSc patient biopsies, with these two NAD-
metabolizing enzymes mapping predominantly to immune (CD38) or stromal (NNMT) cells, respectively; 2)
genetic or pharmacological blockade of CD38 in mice is protective from fibrosis; 3) NAM, the main enzymatic
substrate of NNMT that fuels its activity, is generated via CD38; and 4) NNMT is TGF-ß-inducible, and its
inhibition abrogates fibrotic responses. Our novel paradigm, built upon these observations, implicates
dysregulated NAD metabolism mediated via CD38 and NNMT in the pathogenesis of SSc. Specifically, we
propose that elevated CD38 activity in SSc reduces NAD while generating NAM, both of which then drive
fibroblast reprogramming via fueling NNMT activity and other mechanisms. This metabolic interplay between
CD38-expressing and NNMT-expressing cells might be selectively targeted for fibrosis treatment. Despite our
compelling observations, alterations in the key NAD metabolizing enzymes CD38 and NNMT, and their
pathogenic roles, cellular sources and reciprocal interaction in a metabolic cellular network in SSc have never
been investigated. We will therefore address these critical gaps in this proposal using a comprehensive
experimental strategy deploying patient samples, novel engineered mice and disease models and
pharmacological agents. In Aim 1 we will map CD38 expression in SSc patients and determine CD38's cell
type-specific roles and mechanisms in fibrosis. In Aim 2 we will map NNMT expression in SSc patient biopsies
and determine its cell type-specific pathogenic roles, mechanisms and interplay with CD38. The premise of our
highly innovative proposal is that by elucidating the pathogenic roles and mechanistic links between CD38 and
NNMT underlying dysregulated NAD metabolism in SSc, we will generate fundamental mechanistic
understanding to guide discovery of entirely new treatments to reduce severity of SSc or delay onset of its deadly
complications.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) Based on recent findings from our collaborative laboratories, we propose a very innovative hypothesis for systemic sclerosis (SSc) pathogenesis implicating altered NAD metabolism. This proposal will determine the cellular, metabolic and epigenetic events associated with dysregulated NAD metabolism that underlie pathogenesis and progression in SSc, and can be selectively targeted for effective therapy.